Rapid and economical system for preparation of PFAS samples to lower the Method Detection Limit

Project Abstract
This project aims to develop an innovative and cost-effective PFAS sample preparation (C-
PREP) system that signiflcantly lowers the Method Detection Limit (MDL) and enhances
high-throughput capabilities. Utilizing InnovaPrep’s Concentrating Pipette instrument with
a novel “loosely loaded Concentrating Pipette Tip (CPT)” design termed HIFI-SPE, the
system will overcome limitations of traditional solid-phase extraction (SPE) methods by
reducing sample loading times while maintaining binding efficiency and sensitivity. Key
innovations include sorbent-loaded hollow flber fllters for solid-phase extraction (HIFI-
SPE), integration with patented Wet Foam Elution technology, and the ability to
simultaneously capture and elute PFAS from both free water and environmental particles.
The approach includes optimizing sorbent materials, developing solvent-resistant
components, and utilizing computational Ʋuid dynamics to reflne design parameters.
Preliminary data demonstrates the feasibility of processing 500 mL samples in minutes
with high concentration factors, representing a signiflcant advance in PFAS detection. This
collaborative effort between InnovaPrep LLC and the University of Kansas will result in a
scalable, automated system that provides faster, more sensitive PFAS analysis, addressing
critical needs in environmental and public health monitoring.

Public health relevance
Project Narrative This project aims to develop an innovative PFAS sample preparation system (C-PREP) that significantly lowers detection limits and enhances throughput, enabling faster and more sensitive identification of PFAS contaminants in water. By addressing key bottlenecks in current detection methods and improving the accuracy of environmental monitoring, this system will help users identify and mitigate PFAS contamination more effectively, reducing human and ecological exposure to these harmful substances. The project’s advancements will directly support public health efforts by ensuring safer drinking water, informing regulatory compliance, and enabling more efficient contamination remediation efforts.